Heterogeneous Genetic Architecture in Lung Cancer Risk

Title: Heterogeneous genetic architecture in lung cancer risk
Project Summary/Abstract
Lung cancer is a multifactorial disease driven by environmental exposures, inherited germline genetic
variants, and an accumulation of somatic genetic events. Most lung cancer cases are attributed to cigarette
smoking. Approximately 10% of lung cancer cases have a family history of at least one first-degree relative.
Genome-wide association studies (GWAS) have identified about 45 susceptibility loci directly influencing lung
cancer risk. The genetic architecture in individuals with a family history of lung cancer differs from those with
sporadic lung cancer, although there are common genetic loci influencing both cases. The magnitude of the
association between smoking and lung cancer risk varies by family history status. There is also a familial
component to smoking behaviors, which may confound the association of lung cancer risk with smoking in
hereditary cases.
Each locus, however, exerts only a modest effect, and most of the heritability remains unexplained. New
approaches are therefore needed to address the problem of missing heritability. Since relatively weak signals of
a genetic risk factor are difficult to detect, an improvement would be to jointly model multiple genetic factors to
determine the impact of the risk. Using machine-learning, high-order interaction models among numerous
genetic features in subsets of cases defined according to the family history status, also considering smoking
behaviors can help illustrate how these genetic variants in each stratified subset jointly influence lung cancer
risk.
The overarching aims of this proposal are to characterize the shared and distinct genetic contributions to
lung cancer development and provide better insight into homogeneous and heterogeneous genetic architectures
of lung cancer etiology across family history status in different populations. The specific aims of the proposed
research are to identify the hierarchical combination of multiple genetic variants for lung cancer susceptibility
using machine-learning and to explore in depth the impact of genetic factors in lung cancer GWAS of European-
and African-ancestry populations. This proposal capitalizes on existing well genotype-phenotype repositories of
sporadic and familial lung cancers using subset-based and machine-learning association methods in different
populations. This proposal addresses a comprehensive approach to improve our understanding of how
homogeneous and heterogeneous genetic architectures and biological mechanisms contribute to lung cancer
development and how specific genetic effects, additive, dominant, or recessive, explain lung cancer risk. Finally,
we can identify subgroups of individuals at high-risk based on the individual’s genetic characteristics, with
potential implications for the prevention, screening, and management of lung cancer.

Public health relevance
Title: Heterogeneous genetic architecture in lung cancer risk Project Narrative Large-scale genetic analyses of lung cancer have identified numerous genetic variants influencing both the risk of lung cancer and nicotine dependence, the major risk factor for lung cancer. The proposed research capitalizes on existing well-curated phenotype and genotyped repositories of lung cancer with both sporadic and familial cases in Europeans and African Americans and aims to characterize shared and distinct genetic profiles in lung cancer risk in the different subgroups defined according to family history status of lung cancer using machine- learning. The findings could unravel complex genetic structures of lung cancer etiology, with potential implications for improved prevention, screening, and management of lung cancer.